Hematopoietic and cardiac stem cells from human pluripotent stem cells

DESCRIPTION (provided by applicant): The overall objective of consortium planning is to propose studies to develop new strategies to convert human pluripotent stem cells and somatic cells into hematopoietic (HSCs) and cardiac stem cells (CSCs), through identification of genetic and epigenetic programs leading to formation of pre-HSCs and pre-CSCs and activation of self-renewal program in lineage-restricted cells. Here we combine expertise in basic biology of pluripotent stem cells (Thomson), hematopoietic differentiation (Slukvin) and cardiac differentiation (Kamp), and artificial transcription factors (Ansari) at University of Wisconsin to advance our understanding of HSC and CSC development in humans and develop artificial transcription factor (ATF)-based technologies to generate HSCs and CSCs. We propose the following projects: Project 1) Determine the most critical molecular and cellular events leading to formation of engraftable HSCs and CSCs derived from human pluripotent stem cells. Project 2) Develop artificial transcription factor (ATF)-based technology to convert human pluripotent stem cells and fibroblasts into HSCs and CSCs. The proposed studies will provide new insights into how the hematopoietic and cardiac cells develop in humans, and could ultimately lead to novel and scalable cell source of HSCs and CSCs for therapies of blood cancer and cardiovascular diseases.

Public health relevance
Public Health Relevance Statement In the past two decades, hematopoietic stem cell (HSC) transplantation has become the standard of care for treatment of otherwise incurable disease such as blood cancer. However, insufficient numbers of HSCs, graft failure, and lack of methodology for efficient stem cell expansion in vitro significantly hamper improvements in HSC use in clinical oncology. In contrast, cellular transplantation for heart disease is a relatively new investigational approach which holds great promise to repair the injured heart. Multiple cell sources have been investigated for cardiac cellular therapy, and the recent discovery of CSCs identifies a highly promising cell type for therapeutic applications given the ability to differentiate specifically into all of the major cell types in the myocardium. However, isolation and expansion of functional CSCs from patients with advanced cardiac diseases is a major challenge. The major goal of the proposed studies is to generate HSCs and CSCs from skin cells converted to a pluripotent state. These studies could ultimately lead to novel and scalable cell source of HSCs and CSCs for therapies of blood cancer and cardiovascular diseases.